Exploring a Novel CD8 T Cell Subset in Cardiovascular Disease Progression and Atherosclerosis

Abstract Cardiovascular disease (CVD) kills one in four people annually in the United States and represents a major health concern. Atherosclerosis is the main underlying trigger of CVD and is considered a chronic immune disease, in which antigen-experienced T cells accumulate within atherosclerotic plaques, leading to heart attack and stroke. While plaque destabilization is usually a slow process, diagnosing at-risk individuals often requires invasive methods; thus, there is a growing need to easily identify individuals in danger of heart attack or stroke. Mass cytometry revealed a profound loss of circulating naïve CD8 T cells (TN) in subjects with high compared to low CVD risk. Excitingly, subjects with severe CVD showed a strong increase in a CD8+ TN cell population that expressed the memory antigen CD95. Recently, a CD8+ stem cell memory T cell (TSCM) population, denoted by TN cell markers, expressing CD95, and possessing anti-tumorigenic properties, was identified in humans and mice. This CD8+ TSCM population has not been studied in the context of atherosclerosis. This proposal will test the hypothesis that this CD8+ T cell is a potential biomarker of CVD risk and is pro- atherogenic. To test this hypothesis, we will examine whether CD8+ TSCM cell frequencies are increased in the blood of severe-risk individuals within the Multi-Ethnic Study of Atherosclerosis (MESA) cohort and importantly, enhanced with myocardial infarction (MI) via conventional flow cytometry. CyTOF mass cytometry and single cell RNA sequencing (scRNA-seq) will be employed to identify novel CD8+ TSCM markers. We will also mechanistically determine whether human CD8+ TSCM cells possess a pro-atherogenic phenotype by assessing pro-inflammatory cytokine synthesis. To determine if this novel population worsens atherosclerosis, we will examine whether high fat diet feeding elicits elevated CD8+ TSCM cells within atherogenic Apolipoprotein E-/- (ApoE-/-) aorta and aorta-draining para aortic lymph nodes via flow cytometry. Adoptive transfer of CD8+ TSCM cells into immune-deficient ApoE-/- recipients will be performed to investigate whether this novel CD8+ T cell exacerbates atherosclerosis. These results will provide essential insight into how CD8+ TSCM cells contribute to atherosclerosis. Ultimately, we may unearth a novel CD8+ T cell biomarker (CD95 by TN cells) to better predict CVD-related adverse events, potentially improving diagnosis of at-risk individuals, and ultimately, ridding patients of CVD.

Public health relevance
Narrative Cardiovascular disease (CVD) remains the leading cause of death, with no cure identified to date. While widely used therapeutics, such as statins, target the build up of fat within arteries, none curtail the accrual of effector T cells, including highly activated CD8 T cells within arteries that can halt blood flow. This proposal seeks to investigate the phenotype and functional properties of a novel CD8+ T stem cell memory population increased in individuals with severe CVD risk to identify novel immunological therapeutic targets and biomarkers for earlier and more efficient diagnosis. This proposal also seeks to examine mechanistically how this novel CD8+ T cell contributes to atherosclerosis.